SBIR: In vivo engineering of B7-H3.CAR-T cells for ovarian cancer therapy

Project Summary
T-cells modified with chimeric antigen receptor against unique cancer antigens i.e., CAR-T, represent a
promising form of immunotherapy for cancer, but are currently limited by production time and costs to prepare
the engineered T-cells ex vivo, as well as by modest efficacy against solid cancers due to poor tumor
penetration. Rather than harvesting, activating, transducing, and expanding T-cells ex vivo, we believe direct
engineering of CAR-T cells in vivo, by transducing circulating T-cells with high specificity, will reduce the time
and cost of CAR-T therapy while also maximizing T-cell function by eliminating extended cultures in vitro.
Mucommune has recently in-licensed a platform that enables exceptionally potent yet highly specific
transduction of circulating T-cells, without first requiring T-cell activation, by combining both virological and
chemical approaches. Specifically, it utilizes a LV system incorporating the Nipah virus fusion protein with its
native tropism ablated and retargeted via anti-CD3 scFv, then formulates the resulting Nipah LV (NLV) with a
proprietary combo of transduction enhancers. To date, we have shown that this new system can specifically
transduce non-activated T-cells among circulating PBMCs in vivo, generate CD19-targeted CAR-T that
effectively eliminate the highly aggressive BV173 lymphoma, and generate in vivo-engineered B7-H3-targeted
CAR-T cells that eliminate metastatic non-small cell lung cancer (NSCLC) in vivo.
In this proposal, we will extend this novel NLV platform for engineering B7-H3.CAR-T cells in vivo to
develop more effective T cell therapy against ovarian cancer (OC). Notably, B7-H3 is highly over-expressed in
OC, and there is an ongoing clinical trial at UNC that investigates B7-H3.CAR-T cells prepared using
conventional ex vivo manufacturing. A particular challenge with cell therapies against OC is the
immunosuppressive tumor microenvironment (iTME) imposed by solid OC tumors. Dotti and colleagues
recently showed that dual IL-15 and GPC3.CAR expression can markedly improve the objective response rate
in patients compared to GPC3.CAR alone. Thus, we believe in vivo engineered IL-15.B7-H3.CAR-T should
also offer considerable promise against OC. in Aim 1, we will first engineer and characterize NLVs that encode
both B7-H3.CAR and different forms of IL-15, and evaluate their transduction efficiency in vivo as well as the
effectiveness of IL-15.B7-H3.CAR in co-culture models with different OC cell lines. In Aim 2, we will rigorously
characterize NLV-induced in vivo CAR-T, including T cell memory and exhaustion, compared to conventional
ex vivo engineering CAR-T cells. We will then assess anti-tumor efficacy, prolonged survival and reduction in
metastases in both humanized OC models in NSG mice as well as in syngeneic OC models in
immunocompetent mice. If successful, our work will likely markedly expand the clinical adoption of CAR-T
therapy, both by lowering costs but also potentially broadening their use for treatment of solid tumors, enabling
CAR-T therapy to potentially become a front-line therapy for OC.

Public health relevance
Narrative T cells reprogrammed to display chimeric antigen receptors (CARs) represent a highly promising strategy for cancer therapy, but unfortunately suffer from high costs and modest efficacy against solid tumors. In this proposal, we seek to directly reprogram T-cells that are circulating in the blood to display CAR against the B7- H3 antigen highly overexpressed on ovarian cancers, and evaluate their effectiveness against ovarian cancer in suitable mouse models. If successful, this work will provide the supporting data necessary to advance our strategy into clinical development, potentially enabling more efficacious and cost-effective CAR-T-based therapy for ovarian cancers, the 5th leading cause of cancer death among women.